Epigenetic gene regulation in Arabidopsis

Project Summary/Abstract
Our laboratory focuses on the biology and mechanisms of gene silencing by DNA methylation and histone
modifications, primarily using Arabidopsis thaliana as a model system. Recent efforts have focused on
the mechanisms by which DNA methylation is properly patterned in the genome. The main findings are
that four distinct DNA methylation pathways, driven by four different DNA methyltransferases act in self-
reinforcing mechanisms to maintain cytosine methylation in three different sequence contexts, CG, CHG
and CHH (where H = A, T, or C). The establishment of DNA methylation is controlled by the RNA-directed
DNA methylation pathway, and studying this pathway has been a major recent focus of the lab. Most
recently, the laboratory has used genetics, genomics, proteomics, and structural biology approaches to
characterize the mechanisms by which two RNA polymerases, Pol IV and Pol V, act to produce non-
coding RNAs that act to target RNA-directed DNA methylation to specific loci. The newest findings from
the laboratory are also taking us into new directions aimed at understanding factors that act downstream
of DNA methylation, to both control gene expression and to maintain genome stability. In the next five
years, we plan to utilize all available approaches to understand the proteins that recognize methylated
DNA and certain modified histones, and to decipher their functions in gene expression and in the
maintenance of genome stability. These approaches will include mass spectrometry to directly identify
proteins and protein complexes able to bind to methylated DNA and methylated histones. The laboratory
will also use Arabidopsis mutant screens to identify factors that act downstream of DNA methylation and
various histone marks. A post translational modification of histones called H3K27 monomethylation is
critical for repression of heterochromatin. In the absence of this mark, cells undergo both inappropriate
gene expression and a massive DNA damage response resulting in amplification of heterochromatic DNA.
A key part of the five-year plan will be to understand the mechanisms at play, and to understand the
precise nature of the relationship between gene derepression and DNA damage.

Public health relevance
Project Narrative This research aims at understanding the basic mechanisms by which gene expression is controlled by DNA methylation, which is a chemical modification that occurs on certain genes and prevents these genes from functioning in a particular tissue. When DNA methylation patterns are not properly maintained, this can cause inappropriate regulation of genes and is a major cause of cancer. Thus, a further understanding DNA methylation mechanisms may someday lead to methods for correcting DNA methylation patterning defects.